The Prostate Cancer, Genetic Risk, and Equitable Screening Study (ProGRESS): A pragmatic trial of precision prostate cancer screening

Prostate cancer is the most common non-cutaneous cancer in US men and among Veterans. Many cases are
non-lethal, but prostate cancer remains the 2nd leading cause of cancer death among US men. A major barrier
to reducing the incidence of prostate cancer metastasis and death is the lack of an optimal screening strategy
to identify men at high risk. Screening with prostate-specific antigen (PSA) testing modestly reduces prostate
cancer deaths but increases the morbidity associated with overdiagnosis and overtreatment. Current screening
approaches do not adequately distinguish men without prostate cancer or with low-grade prostate cancer
amenable to active surveillance from men with clinically significant prostate cancer (csPCa), who need
treatment. As a result, guidelines do not recommend universal prostate cancer screening. However, a new
paradigm of precision screening might improve the benefit-to-harm ratio of screening by implementing
screening strategies tailored to an individual's specific genetic profile. Germline genetic testing has emerged as
a powerful predictor for prostate cancer, including csPCa. This includes both rare highly penetrant variants and
polygenic risk scores (PRS), which characterize an individual's predisposition to prostate cancer due to
common genetic variation. Rare and common genetic variation is now an equally powerful predictor of
clinically significant disease as self-reported race or family history. This CSR&D Combined Proof of Concept
and Clinical Trial will evaluate the promise of precision risk stratification to identify men most likely to benefit
from prostate cancer screening. During the proof-of-concept phase, it will achieve the following: 1) Develop a
precision prostate cancer screening intervention consisting of genetic testing for rare variants and a
transancestry PRS for delivery to participants and their primary care providers along with individualized,
genetic risk-informed screening recommendations. 2) Determine the feasibility of enrolling men aged 55-70, at
least 35% of whom are of racial/ethnic minority groups, to a pragmatic randomized clinical trial (RCT)
comparing the precision screening intervention to usual care. 3) Perform an interim assessment to determine
whether the observed trajectory of prostate biopsy event rates is consistent with rates needed to detect a
meaningful between-group difference at the end of the 7-year project period. If feasibility of enrollment and
adequate event rates are demonstrated during the proof-of-concept phase, the RCT will continue to the clinical
trial phase to test the following co-primary hypotheses: 1) Compared with men in the usual care arm, men in
the precision screening arm will have a time-to-diagnosis of clinically significant prostate cancer (csPCa,
defined as NCCN classification intermediate risk or higher) that is not inferior by a margin of >30 days over a
median 4 years of follow-up; 2) Compared with usual care, men in the precision screening arm overall will
undergo fewer prostate biopsies over a median 4 years of follow-up. Pre-specified subgroup analyses will test
these hypotheses in Black men specifically, to evaluate whether this population benefits equally from the
intervention. Enrollees will be followed for additional outcomes including all prostate cancer diagnoses, PSA
testing, prostate MRI, rare variants identified, preferences for or against prostate cancer screening, and health-
related quality of life. The expectation is that precision screening will increase screening among high-risk
patients but decrease screening among low- and average-risk patients, thereby maintaining or improving
overall csPCa detection while improving the population-level benefit-to-harm ratio. Rigorous RCT evidence
that genetic risk-informed screening maintains the benefits of screening while minimizing the harms of
unnecessary procedures and treatments among low-risk men will change clinical practice and policy around
prostate cancer screening.

Public health relevance
Prostate cancer is the most common non-skin cancer among Veterans and the second leading cause of male cancer death. Current methods of screening men for prostate cancer are inaccurate and cannot identify which men do not have prostate cancer or have low-grade cases that will not cause harm and which men have significant prostate cancer needing treatment. False-positive screening tests can result in unnecessary prostate biopsies for men who do not need them. However, new genetic testing might help identify which men are at highest risk for prostate cancer. This study will examine whether a genetic test helps identify men at risk for significant prostate cancer while helping men who are at low risk for prostate cancer avoid unnecessary biopsies. If this genetic test proves beneficial, it will improve the way that healthcare providers screen male Veterans for prostate cancer.